Assessment of Health-Related Work Capacity to Improve Independence of Older Adults

PROJECT SUMMARY
Work capacity is a measure of health expressed in relation to the functional demands of the work
environment. Specifically, it is the capacity to perform a job or set of jobs, and represents the interaction
between an individual’s cognitive, physical, psychomotor, and sensory abilities and the demands of the
job. However, in existing data, individuals’ health-related functional abilities are not measured in a way
that permits direct comparison to the functional demands of occupations. The goal of the proposed
research is to investigate how functional abilities increase and limit work capacity, how these effects
interact with human capital acquired earlier in life, and how opportunities for people with different
functional ability profiles and skills vary across local areas and industries, shaping their prospects for
independence and healthy aging. We will first develop a new conceptual framework for assessing
health-related work capacity which integrates measurement of cognitive, physical, psychomotor, and
sensory abilities with the measurement of occupational ability requirements. Based on this framework,
we will design two surveys that will enable us to assess functional abilities and skills on the same scale
and in the same way in which the ability and skill requirements of occupations in the national economy
are measured. The surveys will be fielded to a nationally representative sample of individuals
regardless of their current work status. We will use the new data to integrate functional abilities and
skills with federal data on occupational requirements to produce individualized estimates of work
capacity. We will analyze how the new measures of health-related work capacity vary by age, how they
differ across demographic groups, and how they are potentially constrained by functional decline in
abilities, skill limitations, and lack of occupational opportunities in local areas and across industries.

Public health relevance
PROJECT NARRATIVE Many older Americans who might like to work are unable to do so because of health-related functional limitations. This project develops a new way of measuring functional abilities that enables direct comparison with occupational requirements. We will use the new measures to identify whether it might be possible to design interventions to restore lost work capacity to individuals whose functional abilities have declined, through accommodation, rehabilitation or retraining.